How the Novel Coronavirus Attacks the Brain

Presentations of patients infected with SARS-CoV-2 are varied and unique in their neurological
manifestations, including loss of smell, confusion, and altered mental status, when the course of the novel
coronavirus disease (COVID-19) is complicated by insults to the neurological system. The nasopharynx and
nasal cavities are reservoirs for high viral load and olfactory tissue contains key receptors and proteases that
may facilitate viral entry and replication at the cellular level. Downstream mechanisms of brain cellular
invasion and integration remain poorly understood, particularly how SARS-CoV-2 may be instigating diffuse
neurological effects. Patients with COVID-19 sustain a severe cytokine storm, the interplay between
inflammation and coagulation combined with endothelial damage, may lead to thrombo-embolic events, and
microglia activation leading to neuronal damage. Patients also present with long-term brain sequela of
COVID-19, including “brain fog,” difficulties concentrating, impaired short-term and working memory, fatigue,
headache, dysautonomia, and insomnia, and the neuropathological bases of these symptoms are unknown.
Appropriate evaluation of specific brain regions from deceased patients with COVID-19 who did and did not
present with neurological symptoms will allow for improved comprehension of possible targets to limit brain
damage. Additionally, lessons from how SARS-CoV-2 affects the brain may provide insight into generalizable
mechanisms for effects of neuroinflammation on neurodegenerative diseases. We aim to determine:
1. Whether COVID-19 patients with neurological presentations at the time of intake (NP-COVs) have altered
brain expression of genes regulating inflammation and coagulation compared to those without (COVs) and
non-COVID-19 age and sex matched controls (CONT). We will map the whole transcriptome in the entire
brain tissue section using single nuclei RNA sequencing (sn-RNA-seq, 10X Genomics). We will validate and
quantify candidate mRNAs expression on neurons, glia, and vasculature-associated cells, using Duplex
RNAscope® (ACDBio), as we successfully performed in CONT. 2. Whether NP-COVs have elevated brain
pro-inflammatory markers. We will run a Human Cytokine/Chemokine/Growth Factor Panel (48 Plex Kit,
Milliopre) and quantify cytokines, chemokines and growth factors. We will map their expression on neurons
and glia, using double immunohistochemistry (IHC), as we piloted in CONT. 3. If NP-COVs have elevated
brain microglia activation. Using double-IHC for microglia markers TSPO (translocator protein), CD11b, Iba1
(Ionized calcium binding adaptor molecule), and neuronal markers, and stereology for cell quantification, we
will compute activated (amoeboid) and resting (small cell body and elaborated thin processes) microglia, and
map spatial relationship to neurons. 4. If NP-COVs have reduced neuronal density and dendrite arborization.
Using double-IHC for neuronal marker NeuN and neurofilament, Stereoinvestigator and Neurolucida (MBF
Inc.), will quantify neuron density, dendrite length and arborization, as in our pilot studies.

Public health relevance
COVID-19 is caused by coronavirus 2 (SARS-CoV-2) infection that often results in abrupt loss of sense of smell as well as other less-defined neurological symptoms. High levels of inflammation, together with vascular damage may be at the basis of brain damage in COVID-19, however, molecular and cellular mechanisms of acute and long-term neurological manifestations of COVID-19 remain unknown. The neurological sequela of SARS-CoV-2 infection may serve as a model for further investigation into neurodegenerative processes that may relate to neuroinflammation and lead to loss of cognitive functions.